Mathematical Models and Statistical Methods for Genome Analysis

DESCRIPTION (provided by applicant): Recent advances in sequencing technology is enabling fast and cost-effective generation of sequence data. Soon, whole-genome sequencing will become a routine assay, opening up new opportunities for biomedical research and related fields. The overall objective of this proposal is to develop accurate, scalable computational methods for whole-genome variation study, both by developing a new theoretical framework for studying population genetics models and by improving the key mathematical component underlying various statistical tools for genome analysis. A common thread that runs through this proposal is recombination. Both crossover and gene conversion recombinations will be considered. The specific aims of the proposed research are: (1) Develop and apply a new theoretical framework that complements the standard coalescent theory when the rate of recombination is moderate to large, thus providing a new set of useful analytic tools to the population genomics community. (2) Devise principled methods to derive accurate multi-locus conditional sampling distributions directly from the underlying population genetics model. Improve the accuracy of a wide range of statistical methods for genome analysis that utilize conditional sampling distributions. (3) Develop scalable computational methods for joint estimation of crossover rates, gene conversion rates, and mean conversion tract lengths from population SNP data. Incorporate realistic biological scenarios into a model with overlapping gene conversions and extend the model to handle ectopic (or non-allelic) gene conversions in multigene families. The above goals will be achieved not by engineering modifications based on intuition or simulations, but by applying and generalizing recent mathematical results that are rigorous and accurate. The new theoretical framework developed in this research will allow one to carry out analytic computation, which was considered to be intractable in the standard coalescent theory with recombination. Furthermore, mathematically justified approximations based on diffusion processes will be devised and portable software packages will be developed for population genomics analysis.

Public health relevance
PUBLIC HEALTH RELEVANCE: The ongoing large-scale sequencing projects will provide a comprehensive view of genomic variation in populations, helping to unravel the genetic basis of human biology and disease risk. Recombination is a major biological mechanism responsible for generating genetic variation in a population, and has important implications for many computational problems in genome analysis, including disease-association mapping and detecting signatures of natural selection. The proposed research will help with analyzing and interpreting whole-genome variation data, by developing novel mathematical frameworks and statistical tools for studying population genetics models with recombination. Project Narrative The ongoing large-scale sequencing projects will provide a comprehensive view of genomic variation in populations, helping to unravel the genetic basis of human biology and disease risk. Recombination is a major biological mechanism responsible for generating genetic variation in a population, and has important implications for many computational problems in genome analysis, including disease-association mapping and detecting signatures of natural selection. The proposed research will help with analyzing and inter- preting whole-genome variation data, by developing novel mathematical frameworks and statistical tools for studying population genetics models with recombination. __SpecificAimsTextDelimiter__ A Specific Aims The overall objectives of this proposal are to develop novel theoretical frameworks for studying population genetics models with recombination, and to apply them to devise accurate statistical tools for analyzing and interpreting whole-genome variation. Recombination is a major evolutionary mechanism responsible for generating genetic variation in a population [14], and has far-reaching implications for disease-association mapping [10,139], missing data imputation [58,88,92,132], phasing genotype data into haplotype data [122,132], inferring local ancestry of admixed populations [114], detecting signatures of natural selection [4,8,35,81,84,109,113,123,136,138], and so on. Two known types of recombination are crossovers and gene conversions, and we will develop computational methods for both types. We recently made novel theoretical advancements concerning recombination. Based on our previous work, we hypothesize that there exists a mathematical theory simpler than the standard coalescent theory that accurately describes the evolutionary dynamics of the relevant degrees of freedom when the recom- bination rate is moderate to large. One of the goals of this proposal is to find that new mathematical description, thus delivering a new set of useful analytic tools to the population genomics community. The specific aims of this proposal are as follows. Aim 1: Develop and apply a novel mathematical framework for studying population genetics models with recombination that complements the standard coalescent theory. a) Find a "dual" stochastic process simpler than the standard coalescent theory that captures the impor- tant dynamics of the relevant degrees of freedom when the recombination rate is large. b) Generalize recent analytic work on closed-form sampling formulas to include higher order terms and to extend to more than two loci. c) Incorporate the analytic sampling formula into the widely-used composite-likelihood method for esti- mating recombination rates. d) Devise methods to utilize quality scores and coverage information in the composite-likelihood method. Aim 2: Improve the accuracy of a wide range of statistical tools involving crossover recombina- tion by devising methods to obtain accurate multi-locus conditional sampling distributions from diffusion processes. a) Develop and apply efficient algorithms for solving large systems of equations to compute the condi- tional sampling distribution for a large number of loci. b) Develop hidden Markov models or dynamic programming formulations for computing the improved conditional sampling probability. c) Generalize the mathematical framework to incorporate subdivided population structure and migration. d) Extend the method to handle missing data. e) Develop portable software that can be adopted by other researchers. f) Use the new conditional sampling distribution to devise a new importance sampling scheme involving both recombination and migration. Aim 3: Develop scalable computational methods for joint estimation of crossover rates, gene con- version rates, and mean conversion tract lengths from population SNP data. a) Develop algorithms to speed up the likelihood computation and optimization in a hidden Markov model with a large state space, and apply it to the gene conversion problem. b) Incorporate realistic biological scenarios into a model with overlapping gene conversions and combine the work described in Aim 2 with the new gene conversion model. c) Extend the model to handle ectopic (or non-allelic) gene conversions in multigene families. d) Generalize the method to handle variable rates. e) Develop efficient software and apply it to obtain genome-wide annotations of the above three param- eters in humans and Drosophila melanogaster.